Mechanisms of DNA Homology-directed Genome Repair and Tumor Suppression

Project Summary
Genetic studies, first done in model eukaryotes and more recently in mammals, have revealed that
homology-directed DNA repair (HDR) plays a critical role in the elimination of DNA double-strand
breaks and in the preservation of stressed or injured DNA replication forks. HDR is reliant on the tumor
suppressors BRCA1-BARD1, BRCA2, and PALB2, mutations in which cause breast, ovarian, and other
cancers. Progress in understanding how these tumor suppressors help mediate HDR and how their
mutational inactivation impacts upon genome integrity has been hampered by the challenge of purifying
them for mechanistic studies. Our research team has overcome this challenge, which uniquely
positions us to decipher the mechanisms by which these tumor suppressors support HDR. In
conjunction with a growing research team in the NCI-designated Mays Cancer Center at the University
of Texas Health Science Center at San Antonio and with external collaborators who are leaders in
structural biology and single-molecule biophysics, we will dissect the underlying mechanisms of
different stages of HDR, to specifically furnish insights regarding the roles of the aforementioned tumor
suppressors therein. We will also pursue chemical screens and synthesis with the Cancer Prevention
and Research Institute of Texas (CPRIT)-supported Center for Innovative Drug Discovery to develop
inhibitors of HDR to use as a chemical biology tool and for preclinical studies. We are confident that our
holistic approach to deciphering HDR mechanisms will provide the foundation for developing targeted
cancer diagnostics and therapeutics.

Public health relevance
Narrative Our elucidation of the mechanisms of homology-directed chromosome damage repair will greatly enhance understanding of the etiology of breast, ovarian, and other cancers. The knowledge garnered from our endeavors will constitute the basis for developing novel cancer diagnostics and therapeutics, and will empower medical practitioners to predict drug response, counsel patients, and explain acquired drug resistance. !